Federal Minimum Wage Expansion and Home Care Utilization and Costs for Older Adults

Abstract. Over 70 percent of older adults aged 65 or older require assistance from caregivers with basic
functions at some point in their lifetime, and more than six million older adults in the US have Alzheimer’s
disease and Alzheimer’s disease-related dementias (AD/ADRD) and require more extensive assistance than
their counterparts without AD/ADRD. As the US population is aging and more people seek to age in their
homes instead of moving to institutional care facilities such as nursing homes, there is a substantial need for
in-home healthcare and supportive services. Home care services provided by home care workers therefore
play an increasingly crucial role in the US health care system. Indeed, the home care workforce has become
one of the fastest growing occupations in the nation. However, the Federal Fair Labor Standard Act (1938)
excluded home care workers from the federal minimum wage and overtime protection under the
“companionship exemption”, which contributed to the challenging labor market conditions for home care
workers and could in turn have a negative impact on older adults who needed high-quality home care services.
In 2013, the Department of Labor narrowed the “companionship exemption” and promulgated the “Home Care
Rule” (HCR) by allowing certain types of home care services to be protected by federal minimum wage and
overtime rules. The new HCR came into effect in January 2015. This new HCR affected states differently due
to variations in pre-existing state regulations on minimum wage exemptions, rates and overtime pay, providing
a natural experiment that we explore in this study to provide the first empirical evidence on the effects of the
new HCR on older adults’ utilization of and spending on home (and other forms of) care. We will use
difference-in-differences and event-study approaches along with large, nationally representative datasets to
pursue the following two interrelated aims in this quasi-experimental study: Aim #1: We will test how the new
HCR has changed older adults’ utilization of home care services, using self-reported individual-level measures
of utilization from the Health and Retirement Study (HRS) data and county-level measures of utilization from
the Geographic Variation Public Use File developed by the Center for Medicare and Medicaid Services. Aim
#2: We will test how the new HCR has changed older adults’ spending on home care, using the same two
datasets for Aim 1A. We will explore the heterogeneous effects of the new HCR on older adults’ utilization of
and spending on home care along key dimensions including their AD/ADRD status using the HRS data. This
study directly serves the overall purpose of NIH PAS-19-391, namely, “…to provide needed scientific insight to
improve the prevention, diagnosis, treatment, and/or care for individuals with Alzheimer's disease and
Alzheimer's disease-related dementias (AD/ADRD)” by “leveraging existing data”. Findings from this study will
have significant policy implications, as the size and the life expectancy of the older adult population, especially
the population with AD/ADRD, and the costs of health care continue to rise.
1

Public health relevance
Narrative This project aims to examine the effects of the new Home Care Rule (HCR) by the Department of Labor which allowed certain types of home care services to be protected by federal minimum wage and overtime rules in 2015, using advanced empirical methods and two large, nationally representative data sets. This new HCR could substantially change the utilization of and the spending on home care service for older adults with and without Alzheimer’s disease and Alzheimer’s disease-related dementias (AD/ADRD). Findings from this study will have significant policy implications, as the size and the life expectancy of the older adult population, especially the population with AD/ADRD, and the costs of health care continue to rise, putting unprecedented pressure on the health care system.